RAND REACH Center

There is a compelling need to foster the development and research careers of clinician-scientist faculty at accredited academic institutions that graduate complementary and integrative health (CIH) professionals. Well-trained, well-resourced, and collaborative clinician scientists are essential to high-fidelity innovative research of complementary and integrative interventions that can improve health outcomes. Clinician-scientist faculty at CIH institutions are also in an optimal position to understand and help answer research questions that are essential to advance the science of CIH. Further, their interaction with students may encourage some to consider future careers as clinician scientists, and more broadly will expose all students to critical thinking and allow them to be better future clinicians committed to staying current on the latest scientific evidence.
The overarching goal of this application is to create a virtual resource center for REsearch Across Complementary and Integrative Health (REACH) institutions. The purpose of this REACH Center is to provide resources for collaboration across clinician-scientist faculty located at CIH clinical institutions. This REACH Center will take advantage of a successful effort begun in 2020 by Drs Herman and Coulter, the RAND Center for Collaborative Research in CIH (RAND Center). The purpose of the RAND Center was to initiate research collaborations between 13 CIH clinical institutions in the US and Canada. At the core of this effort is a web-based members-only platform built using user-centered design with input from member researchers. This collaboration has been awarded 3 of 7 research proposals submitted, each funded by a different organization.
While satisfaction with the current RAND Center is universally high, presidents of the 13 partnering institutions agree that the advances of REACH, as outlined in these Specific Aims, would greatly enhance their collective research success, and have expressed their full support for this application. These are the Aims:
Aim 1: Foster and enhance a virtual research community across the Center’s multi-disciplinary partners in which collaborative research concepts can be incubated into successful grant submissions resulting in findings which will improve symptom management and whole person health using CIH interventions.
Aim 2: Provide core research resources to Center members including biostatistical and clinical informatics support, consultation on research design, grants administrative support, and collective software/datasets.
Aim 3: Facilitate research training and mentoring to improve grant applications and support the progression of clinician-scientists into successful research careers.
Aim 4: Outreach for additional CIH clinical institution partnerships will occur throughout the support period.
Achieving these Aims will increase research capacity within CIH clinical institutions, augment clinical research training pipelines, improve research knowledge and skills within partnering institutions and facilitate the creation of a strong research environment and the next generation of critically thinking CIH clinicians.

Public health relevance
PROJECT NARRATIVE There is a compelling need to foster the development and research careers of clinician-scientist faculty at accredited academic institutions that graduate complementary and integrative health (CIH) professionals both to ensure high-fidelity innovative research on CIH and advance the science of CIH, but also to expose students to critical thinking and careers in research. The overarching goal of this application is to create a virtual resource center for REsearch Across Complementary and Integrative Health (REACH) clinical institutions to provide resources for collaborative research across clinician-scientist faculty located at these institutions. This REACH Center will take advantage of and build upon a successful effort begun in 2020 by Drs Herman and Coulter, called the RAND Center for Collaborative Research in CIH (RAND Center).